A Pragmatic Trial to Determine the Benefit of Behaviorally Enhanced Exercise Incentives and Corticosteroid Injections in Osteoarthritis of the Knee

Knee osteoarthritis (KOA) is one of the most prevalent and disabling conditions among veterans and accounts
for high morbidity and high costs for the VA. Importantly, chronic reductions in physical activity in patients with
KOA may worsen pain, physical function, and exacerbate the metabolic consequences of obesity. The current
proposal aims to address two important knowledge gaps in the management of KOA in order to improve pain
and function. Promoting physical activity has been shown to be helpful in reducing pain and improving function
in KOA, however, reliable ways to change behavior that can be easily employed are lacking. Our group has
shown that social incentives derived from concepts from the field of behavioral economics to promote
behavioral change and increase physical activity can be both practical and effective in other settings. The
efficacy and safety of incentivizing physical activity using these approaches has not been studied in patients
with KOA. Furthermore, whether adjunct therapies such as corticosteroid injections may be a helpful to reduce
pain and disability and increase physical activity is unknown and is an additional knowledge gap addressed by
the current proposal. Despite widespread use, definitive data to quantifying the benefit, if any, of corticosteroid
injections are lacking. A large randomized trial tested the effects of corticosteroids injections every 3 months
for a period of 2 years on patient reported pain. This study demonstrated no improvement in pain compared to
saline and a small decline in cartilage thickness on MRI in the corticosteroid group. These data might suggest
that corticosteroid injections result in more harm than good, however, there are critical weaknesses to this
study including that pain and function were only assessed at 3-month intervals, while previous trials have
suggested that peak benefit is expected at 4-8 weeks. We propose to fill these important knowledge gaps with
an innovative and efficient pragmatic study. The aims are (1) To determine whether an incentive based on
behaviorally-enhanced gamification can improve physical activity among patients with KOA and
reduce self-reported pain and disability, and (2) to determine if corticosteroid injections can reduce
pain and disability in patients with KOA when compared to lidocaine only. This double-blinded
randomized clinical trial of 220 patients using a factorial and crossover design will leverage unique resources
available through the Penn Center for Innovation to capture important patient-reported outcomes. We will
randomize participants to receive social incentives with gamification to promote increases in physical activity.
Each patient will also receive both corticosteroids and saline in random order. We will utilize innovative mobile
applications for smart phones and wearable activity trackers through the Way-to-HealthTM platform and assess,
in real time, the impact of the interventions on patient-reported function and pain as well as physical activity.
The technology will allow for the recording of outcomes as they occur, thereby avoiding information bias due to
poor recall. The study will determine the benefit of social incentivization to promote increases in physical
activity in patients with KOA and to determine the efficacy of corticosteroid injections for improving function,
increasing physical activity, and reducing pain. Our RR&D funded pilot study demonstrated high feasibility and
provided important preliminary data to accurately power the larger study. The study includes experts across
multiple disciplines and also leverages existing networks and infrastructure that will ensure feasibility through a
strong organizational structure and close collaboration between investigators.

Public health relevance
Reductions in physical activity contribute to pain, physical dysfunction, and adverse long-term health consequences in patients with knee osteoarthritis (KOA). We propose to address this important knowledge gap with a practical clinical trial of 220 patients using resources available through the Penn Center for Health Innovation and an innovative crossover and factorial design. This study will build off of a successful pilot study and evaluate the benefit social incentives in combination with corticosteroid injections to improve physical activity and reduce pain and disability in KOA using real-time assessment of outcomes using mobile applications for smart phones and physical activity trackers.